FAMILY FUNCTIONING &EXPECTATION OF CHILDREN WITH SICKLE CELL ANEMIA

The occurrence of cognitive deficits and decreased academic performance in children with sickle cell disease (SCD) is well documented in the literature, most of it being attributed to school absenteeism or low socioeconomic status (SES). However, there has been a notable lack of exploration on the effects of the family's role, particularly the parent's expectations, in mediating the impact of this chronic illness on their children. This is a critical issue since the literature suggests that the most important factor in a chronically ill child's life is the family relationship. It is a particularly crucial issue for the SCD population, the majority of whom are either underemployed or worse, unemployed. However, the disease process of SCD, often overlooked in discussions of decreased cognitive performance in children with SCD, should not be ignored. The relationship between SCD and pathology of the central nervous system, the high incidence of stroke in young children with SCD (5-10%), and the significant number of children with SCD who do not display any overt symptomatology of neurologic disease but exhibit decreased academic performance in comparison to healthy matched peers clearly suggest the disease process as a primary contributing factor to long-term cognitive deficits often demonstrated by the adult SCD population. Medical and psychological researchers have proposed chronic microvascular insults, small hemorrhages, and progressive vascular disease as disease process factors responsible for lowered academic and cognitive achievement. The overall purpose of this study is to identify family and disease related factors that contribute to cognitive deficiencies associated with children with SCD who have not exhibited any clinically apparent neurological abnormalities. Fifty infants and toddlers with SCD and 50 matched normally developing peers between the ages of birth and 2 years will serve as subjects in a 5 year longitudinal design. Subjects will be tested repeatedly at various milestones and stages of development with developmental, intellectual, achievement, family functioning and physiological assessments. An important feature in this proposal is the inclusion of MRI technology in order to study the neuroanatomical effects of SCD. Thus, this research will allow for the comprehensive study of cognitive deficits in SCD during important developmental years, utilizing psychosocial and physiological measures. The goals of this study are to: a) determine if cognitive dysfunction in SCD is related to hypoxic/ischemic brain damage; b) determine if family expectations and functioning affect cognitive performance; c) assess the relationship between cognitive performance and disease severity, knowledge of sickle cell disease, and social status.